Modeling the Co-evolution of Substance Use behavior and peer Networks of risk/support (CoSUN)

Drug overdose deaths in the U.S. have continued to increase over the years, with over 70,000 deaths
in 2019. The economic cost of substance use and abuse related crimes, healthcare, and loss in work
productivity in the U.S. exceeds $600 billion each year. In order to aid individuals and reduce the
associated cost effectively, we must allocate appropriate resources to individuals in the greatest
emerging need (e.g., those of high future substance use). However, there are currently no data-driven
tools that allow stakeholders to (stochastically) forecast an individual's substance use. Current
methodologies only rely on trend analyses, establishing correlations between risk factors (e.g., friends
that use drugs) and substance use. A key challenge we are facing when modelling future substance use
lies in the co-evolution of behaviors (i.e., drug use) and peer networks of risk/support, which can
change over time and may depend on each other. To address this scientific obstacle, we consider an
innovative approach that decouples the co-evolution process of substance use and peer risk/support
networks by (Aim 1A) first modelling how individual attributes (e.g., drug use and adverse childhood
history) along with their peer networks (e.g., the extent of peer and confidant drug use) impact the
individual’s substance use behavior and (Aim 1B) then modeling how individuals’ peer risk/support
network links form or break in response to similarities or differences in the endpoints’ attributes (e.g.,
their drug use behaviors). Thus, for the first time, this project seeks to develop stochastic forecasting
models for future substance use (FSU) and future peer risk/support networks (FPN) at long timescales
within months (Aims 1-2) and for FSU at short timescales within days (Aim 3) using data on covariates
of individual attributes and peer network features. We will use successful machine-learning methods to
build these models and rigorously assess model generalizability/prediction performance (Aims 1-3) by
making use of data that is held-out from the model building process. The Aims will provide a foundation
for a future innovative NIH R01 that develops stochastic simulations of realistic SUD-related behavioral
contagion in plausible dynamic networks, to inform resource allocation and contingency planning. This
project also lays the groundwork for just-in-time interventions to detect imminent increases in FSU and
use these risk forecasts to trigger the delivery of social and behavioral interventions.

Public health relevance
Substances such as methamphetamine, cocaine, and opioids can create short-term and long-term negative effects, including drug overdose, death, and HIV/AIDS, on users’ health and wellbeing. Thus, there is an urgent need to identify individuals that are in the greatest emerging need for prevention and treatment interventions before manifestations of these effects. This project addresses such a need by modelling future substance use, which can be used to inform policymakers’ resource allocations and aid healthcare providers in contingency planning and the optimal deployment of interventions.